Administrative Core

The mission of the Northern New England Clinical and Translational Research Network (NNE-CTR) during the
initial funding period has been to develop and sustain a clinical and translational research infrastructure that
supports improvements in rural and community health in the IDeA states of Maine, New Hampshire and
Vermont. The Administrative Core has developed the infrastructure to oversee the interactions of primary
healthcare providers, clinical investigators, scientists, trainees, navigators, and community members to
conduct clinical and translational research, with the goal of improving healthcare delivery, health outcomes,
and population health in northern New England. The primary focus of the NNE-CTR is on health challenges
affecting northern New Englanders, with a special emphasis on health disparities and inequities encountered in
underserved urban and rural populations and the barriers to prevention and treatment of chronic diseases and
rural healthcare delivery. Three specific aims are proposed for this renewal application: 1) continue to oversee
and develop the research infrastructure to support, maintain and grow clinical and translational investigation,
with a priority on expanding clinical trials to reach rural areas of northern New England, while embracing
diversity through cultural training and mentoring of NNE-CTR members; 2) expand infrastructure to enhance
collaborations with other CTRs and CTSIs for national initiatives; and 3) strengthen NNE-CTR support and
expand leadership and collaboration with the Northern New England PBRN. The NNE-CTR will continue to
build and sustain an infrastructure, supported by the principles of diversity, equity and inclusion, for clinical and
translational scientists, leveraging the expertise of the two lead institutions and their partners. The NNE-CTR
will provide the platform for enhancing clinical research, healthcare delivery, and improving health outcomes
for the rural and underserved residents of northern New England.